Clinical Decision Support for Assessing Pulmonary Embolism using Machine Learning

Project Summary/Abstract
Minnesota HealthSolutions (MHS) proposes a Phase II project to develop and validate a software product
capable of automatically detecting and staging pulmonary embolisms (PEs) using clinically routine pulmonary
CT angiograms (CTAs). The proposed system will combine state-of-the-art machine learning methods and the
clinical expertise at Duke University into a system that integrates seamlessly into the Radiology workﬂow and
standard patient care path to improve the treatment decisions of physicians in the emergency department.
Pulmonary embolism is the third most common cause of death in hospital patients with an estimated
incidence of 1 per 1,000 patients. CTAs are routinely used to detect PE today; however, there is signiﬁcant
variability in the detection rate among radiologists using CTA. Furthermore, despite the strong evidence that
the RV/LV ratio is an important clinical biomarker it is rarely measured quantitatively in practice. A successful
completion of this project would provide a workﬂow-integrated tool capable of faster PE detection and more
accurate staging of right heart strain to guide the physician’s treatment decision.

Public health relevance
Project Narrative The proposed project seeks to develop and validate a software system that can use routine pulmonary CT angiograms to guide pulmonary embolism intervention decisions. Pulmonary embolism is the third most common cause of death in hospital patients with an estimated incidence of 1 per 1,000 patients. A successful completion of this project would provide a tool capable of faster PE detection and more accurate staging of right heart strain to guide the physician’s treatment decision.